Project 4: Activity of CAR T cell Therapy for Patients with Metastatic TNBC

PROJECT 4: Activity of Car T Cell Therapy for Patients With Metastatic TNBC - Abstract
Triple negative breast cancer (TNBC) remains a tumor with dismal prognosis even in the era of immune
checkpoint inhibitors (ICIs). Here we propose to develop chimeric antigen receptor T cells (CAR-Ts) to target
TNBC. Specifically, we will target the B7-H3 antigen that is aberrantly expressed in several solid tumors
including TNBC, but has limited expression in normal tissues. In Aim 1, we will conduct a Phase I clinical study
infusing autologous B7-H3.CAR-Ts in patients with TNBC.
Solid tumors including TNBC are characterized by heterogeneity of antigen expression and can escape
immune targeting directed against a single antigen. Furthermore, brain metastases of TNBC remain difficult to
treat due to the presence of the blood-brain-barrier (BBB) that poses physical impediment to both drugs and
immune cells.
In Aim 2 we propose to develop preclinical models of TNBC to test dual CAR-Ts targeting B7-H3 and
chondroitin sulphate proteoglycan 4 (CSPG4) using a novel dual CAR design and to engineer dual CAR-Ts to
express the CCR2b chemokine receptor, which we found to promote CAR-T cell trafficking through the BBB
when brain metastases produces the CCL2 chemokine.
The inhibitory TME contributes to attenuating CAR-T cell functions. We implemented a model of CAR-Ts in
immunocompetent mice and demonstrated that Th/Tc17 polarized CAR-Ts combined with STING agonists
prompted superior tumor control compared to conventional CAR-Ts. Furthermore, STING agonist 2'3' cGAMP
leads to significant enrichment of T cells with stem cell (TSCM) and central-memory (TCM) characteristics both in
vitro and in vivo. In Aim 3, we will assess the mechanism and antitumor activity of Th/Tc17 CAR-Ts activated
by cGAMP in modulating the breast cancer TME and enhancing the expansion of CAR-Ts in the TME.

Public health relevance
Project 4: Activity of CAR T cell Therapy for Patients with Metastatic TNBC - Narrative We have had success in treating patients with hematological malignancies by using their own immune cells modified with a chimeric molecule that eliminates tumor cells but spare part of the immune B-lymphocytes. In this project we intend to conduct a Phase I clinical trial to test safety and antitumor activity of a novel chimeric antigen receptor in patients with triple negative breast cancer (TNBC). Furthermore, we will implement novel approaches to enhance our capacity to generate more functional T cells for adoptive T cells therapy.